Pediatric Brain Tumor Consortium A multi-institutional consortium devoted to novel phase I and II clinical evaluations of experimental treatment approaches for pediatric CNS tumors

PBTC Project Summary/Abstract
The primary goal of the Pediatric Brain Tumor Consortium (PBTC) is to rapidly and effectively
contribute to the understanding and cure of pediatric central nervous system (CNS) tumors
through innovative, multidisciplinary and multi-institutional prospective clinical trials. PBTC clinical
trial development is not only based upon known prognostic factors but also upon an evolving
understanding of pediatric brain tumor biology. The PBTC will continue to utilize innovative study
designs and analyses based on state-of-the-art statistical science. Novel clinical trials will
incorporate relevant correlative pharmacology, biology, neuroimaging, immunologic and
genomics studies in an effort to define and integrate these modalities into a better understanding
of pediatric CNS tumors. These goals will be accomplished through a close and continued
partnership with the member institutions' basic and translational scientists as well as the clinical
trial experts. In addition, the PBTC welcomes partnerships with investigators outside the
consortium providing scientific, laboratory and regulatory support for innovative and high priority
clinical trials. The PBTC will continue to maintain and grow its relationship with the National
Cancer Institute (NCI) and its large network of adult and pediatric groups as well as with
pharmaceutical and biotechnology companies. One of the most important goals of the PBTC is to
successfully complete focused phase I and II clinical trials of novel agents and treatment
approaches that can be then be translated into large prospective phase II and III studies overseen
by the Children's Oncology Group (COG). The overarching long-term goal is to improve survival
outcome and quality of life for children with CNS tumor diagnoses that so often lead to high
morbidity and mortality such as diffuse intrinsic pontine gliomas, high-grade gliomas, infant
embryonal tumors, refractory medulloblastoma, ependymoma, and low-grade gliomas. To this
end, the PBTC will continue to focus upon introducing novel molecularly-targeted agents via
innovative trials to assess the presence of the target in tumor and surrogate tissue, evaluate the
ability of the agent to down-regulate its signaling target and better correlate pharmacokinetic and
pharmacodynamic endpoints with toxicities and clinical responses. The PBTC will also continue
to explore therapeutic opportunities for pediatric brain tumors through immunotherapeutic
interventions as well as via local delivery of treatments. By focusing on the most common solid
tumor in children which also accounts for the highest number of cancer-related deaths in
pediatrics, the PBTC will continue to support the NCI's mission of helping all people live longer,
healthier lives through its contributions to cancer research and identification of better treatments.

Public health relevance
PBTC Project Narrative and Overall Summary Organization of the PBTC Since its inception in 1999, the PBTC's primary objective has been to rapidly conduct novel phase I and II clinical evaluations of new therapeutic agents, treatment delivery technologies and radiation treatment strategies in children from infancy to 21 years of age with primary central nervous system (CNS) tumors. In Figure 1- PBTC Site Locations addition, the Consortium aims to characterize reliable markers and predictors (direct or surrogate) of brain tumors' responses to new therapies. The Consortium conducts research on brain tumor specimens in the laboratory to further understand the biology of pediatric brain tumors. The 15 current full-member institutions of the PBTC include the Children's Healthcare of Atlanta, Children's Hospital Colorado, Children’s Hospital Los Angeles, Children’s UPMC Hospital of Pittsburgh, Children’s National Medical Center, Cincinnati Children's Hospital Medical Center, Dana-Farber Cancer Institute, Hospital for Sick Children, Toronto, Lucile Packard Children's Hospital Stanford University, Ann & Robert H Lurie Children’s Hospital of Chicago, Memorial Sloan Kettering Cancer Center, Nationwide Children’s Hospital, St. Jude Children’s Research Hospital, Texas Children's Hospital, and the University of Florida. In addition, the NCI-Pediatric Oncology Branch is a special member of the PBTC. The PBTC is chaired by Ira Dunkel, MD who is an Attending in the Department of Pediatrics at the Memorial Sloan Kettering Cancer Center and a Professor of Pediatrics at the Weill Cornell Medical College. He serves as the co-principal investigator (PI) of the PBTC Grant as well as the Chair of its Steering Committee. The PBTC is managed through the Operations, Biostatistics and Data Management Core (OBDMC) located at St Jude Children’s Research Hospital. Arzu Onar- Thomas, PhD is the Executive Director of the OBDMC and the co-PI of the PBTC grant. She is a Full Member (equivalent to Professor rank) of the St. Jude Department of Biostatistics. Jason Fangusaro, MD is the Vice-Chair of the PBTC, and is the head of the Developmental Therapeutics at Children’s Healthcare of Atlanta and a Professor of Pediatrics at the Emory School of Medicine. The PBTC Steering Committee is the executive body, comprised of the PIs of the 15 full- member institutions, PI of NCI-POB, the chair of the Parent/Advisory Committee and the Executive Director of the OBDMC. The PBTC NCI representative Malcolm Smith, MD, PhD, serves as an ex officio member. The Steering Committee meets during each of the biannual meetings and convenes by conference call on an as-needed basis. The Steering Committee also advises the consortium on important initiatives including re-competition for new members, consortium scientific priorities, operational practice changes etc. It also oversees the institutional performance managed by the PBTC Quality Assurance Committee and provides oversight for fiscal activities. The PBTC Executive Committee is comprised of Drs. Dunkel, Onar-Thomas, Fangusaro, as well as Drs. Patricia Baxter, Ian Pollack, and Roger Packer. This committee meets on an as-needed basis to provide advice and direction to optimize the scientific, research and clinical operations of the PBTC and to assist in prioritizing the development of clinical trials. The scientific plans, reviews, and prioritization for the Consortium are managed through the PBTC Scientific Committee, comprised of the members of the Steering Committee, member institution co-PIs, chairs and co-chairs of the Consortium’s disease and discipline committees (AYA, embryonal tumors, ependymoma, HGG/DIPG, immunotherapy, LGG, local delivery/neurosurgery, new agents, and radiation oncology), and chairs of the PBTC Cores (PK, Neuroimaging, and Biorepository). The Scientific Committee critically reviews and scores new concepts and initiatives and provides input for clinical and operational issues. The committee meets monthly via conference call and during each of the biannual meetings. Each of the PBTC disease and discipline committees is responsible for developing and shepherding new concept proposals, reviewing and developing opportunities for the Consortium, and providing appropriate interface with the overarching objectives in biology and Figure 2 - Regulatory, Clinical, and Scientific infrastructure neuroimaging. A summary of PBTC’s regulatory, clinical, and scientific activity infrastructure is provided in Figure 2. PBTC Project Goals and Summary of Accomplishments 2019 RFA Goal 1 Evaluate novel treatment approaches based on research opportunities developed within the PBTC institutions, within the COG CNS committee, or from data leveraged from pharmaceutical companies. During the current grant cycle, the PBTC has continued to evaluate innovative clinical trials in pediatric brain tumors. The details of these studies are discussed throughout this document, and they are summarized below by disease type and status. Table 1: PBTC clinical trials that were active throughout the reporting period & current PBTC- approved LOIs per disease type & status Disease Newly diagnosed Recurrent disease DIPG PBTC-047 panobinostat PBTC-048 RT + Optune PBTC-051 APX005M PBTC-060 SurVaxM PBTC-047 panobinostat PBTC-049 savolitinib PBTC-050 ribociclib, everolimus PBTC-056 INCB007839 HGG PBTC-045 pembrolizumab PBTC-048 RT + Optune PBTC-049 savolitinib PBTC-050 ribociclib, everolimus PBTC-051 APX005M PBTC-055 dabrafenib, trametinib, HCQ PBTC-056 INCB007839 PBTC-060 SurVaxM PBTC-061 G207 + RT LGG PBTC-029B/C selumetinib PBTC-055 dabrafenib, trametinib, HCQ C176/PBTC-062 LITT Ependymoma PBTC-045 pembrolizumab PBTC-048 Novocure (supratentorial) PBTC-050 ribociclib, everolimus PBTC-051 APX005M PBTC-058 IT 131-I-8H9 PBTC-059 HER2 CAR cells PBTC-060 SurVaxM Medulloblastoma PBTC-045 pembrolizumab PBTC-049 savolitinib PBTC-050 ribociclib, everolimus PBTC-051 APX005M PBTC-053 CX4945 PBTC-058 IT 131-I-omburtamab PBTC-060 SurVaxM 2019 RFA Goal 2 Conduct pilot studies, phase I & II studies that require the specialized abilities of experienced neurosurgeons, neuro-oncologists, radiation oncologists, & neuroimagers. Neurosurgery: Pediatric neurosurgeons play key roles in several PBTC studies. PBTC-053 and PBTC-059 contain surgical strata in which the study agent is administered prior to clinically indicated neurosurgical procedures, providing an opportunity to study intra-tumoral agent concentrations and biological effects. PBTC-058 involved intra-ventricular administration of the study agent 131-I-omburtamab, requiring placement of an Ommaya reservoir or a programmable VP-shunt. In PBTC-061 the study agent G207 is administered by the neurosurgeon after placement of several intra-tumoral catheters. PBTC-062/C176 is a proposed study of LITT, a treatment performed by neurosurgeons, that is under CTEP review. These key studies depend on the expertise of trained and experienced neurosurgeons at each participating PBTC site. Radiation oncology: PBTC-048 (Optune) has been amended to add a new stratum in which patients with newly diagnosed DIPG will receive concurrent RT and Optune followed by maintenance Optune post-RT. Pre-clinical work justifying the possibility of keeping the Optune arrays in place during RT was performed by Dr. Chris Tinkle, head of the PBTC radiation oncology committee. In the PBTC-061 study, a single fraction of RT will be administered shortly after the intra-tumoral G207 administration, requiring close coordination between the pediatric neurosurgeon and the radiation oncologist. Neuroimaging: The neuroimaging group led by Dr. Tina Young-Poussaint has had a long history of performing correlative clinical research within PBTC and recently has taken on other crucial responsibilities within PBTC trials. The PBTC-055 phase II inclusion criteria required a real- time central review of prior scans as part of eligibility to document that the subject either progressed while on targeted therapy or only achieved stable disease as a best response. The PBTC-058 study team includes nuclear medicine physicians and radiochemists involved in the radiolabeling of the 131-I-omburtamab and in the interpretation of the SPECT scans obtained for dosimetry. The PBTC-061 team performs real-time imaging review to confirm eligibility. 2019 RFA Goal 3 Implement laboratory studies (including PKs, PDs & genomic characterization) related to PBTC clinical trials, with a goal to identify tumor-intrinsic factors associated with treatment response & to monitor or measure biological responses that may provide information relevant to the success or failure of therapy. PK: Clinical pharmacology studies are routinely included in PBTC clinical trials. Aims include studying drug disposition over a range of drug dosages, comparing the PK/PD of drugs tested in children with those observed in adults, and evaluating potential drug-drug interactions. During the last funding cycle PK/PG studies were completed or initiated for a variety of cytotoxic and molecularly targeted agents: Table 2: PK Studies COMPLETED ONGOING Study Phase Agent Publication Study Phase Agent 029 II, Strata 1 and 3 Selumetinib Fangusaro 2019 049 I Savolitinib 053 LC MS/MS CX-4945 Zhong 2020 053 I CX-4945 033 I/II ABT-888 Baxter 2020 055 I Trametinib/ Dabrafenib/ Hydroxychloroquine 043 I Pomalidomide Fangusaro 2021 056 I INCB007839 042 I Palbociclib Van Mater 2021 029B II, Stratum 4 Selumetinib Fangusaro 2021 050 I Ribociclib/Everolimus De Wire 2021 In addition to the studies performed by PBTC PK Core (Stewart lab, St. Jude), PBTC clinical trials also have had PK studies performed at labs determined by the pharmaceutical sponsor. These PK/PD studies are essential in our understanding of these drugs, often being tested in children with brain tumors for the first time. Genomics: Genomic studies continue to play an important role in the PBTC, particularly in determining eligibility for many of our studies. Current examples of this include PBTC-045 stratum C (hyper-mutated tumors), PBTC-049 efficacy expansion (c-met aberrations), PBTC- 053 (SHH medulloblastoma), and PBTC-055 (BRAFV600E mutations, BRAF fusions). PBTC N14 (activated in July 2023) is a non-therapeutic study of CSF cfDNA performed as a clinical test, so the results are clinically actionable and intended to help with diagnosis and treatment decisions. Patients may enroll in this study with and without participation in a PBTC therapeutic study. The primary objective of the study is to estimate the concordance of mutations detected in the tumor tissue vs. CSF cfDNA (within specific histologies) across samples collected within 8 weeks of each other and to determine whether clonal mutations are likely to be shared across sample types. Secondary objectives include estimating the frequency of detection of CSF cfDNA across different types of pediatric CNS tumors in association with various disease states and to track and estimate the correlation between the levels of CSF cfDNA and disease response as determined by clinical and imaging criteria across different disease types. 2019 RFA Goal 4 Explore treatment options for brain tumors with specific genomic & epigenomic features, including LGG with BRAF & other MAPK pathway mutations, medulloblastoma & ependymoma subtypes, & HGG with H3.3 mutations. LGG: LGG has been a major focus of PBTC efforts, and one of our most notable accomplishments has been PBTC-029 which determined the safety and efficacy of the MEK inhibitor selumetinib in pediatric patients with recurrent or refractory LGG. Multiple strata were investigated, and activity noted in pilocytic astrocytomas with BRAF fusions/mutations, optic pathway tumors, and tumors in patients with NF1. These results stimulated the Children’s Oncology Group to develop 3 trials including two phase 3 trials in patients with previously untreated LGG (one in patients with NF-1 [COG ACNS1831] and the other in patients without NF-1 [COG ACNS1833]) and another Phase III study in recurrent LGGs [COG ACNS1931] comparing targeted therapy to a combination of vinblastine plus targeted therapy. Final analyses of the other PBTC-029B strata (2, 5, and 6) have been completed recently and associated manuscript has been submitted to NeuroOncology. Stratum 2 evaluated the use of selumetinib (a MEK inhibitor) in patients with PA without the common BRAF aberration; stratum 5 included children with non-pilocytic astrocytoma that possess one of the 2 most common BRAF aberrations; and stratum 6 was for children who submitted tissue for eligibility for strata 1, 2 or 5 and there was an assay failure. The re-treatment study PBTC-029C was for children who achieved a prolonged SD or PR on PBTC-029 and then progressed after stopping selumetinib. The follow-up for this cohort is complete and the associated manuscript will be completed in the next year. These PBTC data are being utilized by Alexion/Astra Zeneca to apply for a new FDA indication for selumetinib. PBTC-055 is the current phase I/II PBTC LGG study which closed to accrual on 12/31/2024, and it also includes a stratum for patients with BRAFV600E mutant HGG. It explores the hypothesis that autophagy is an important mechanism of resistance or inadequate response to targeted therapy based upon pre-clinical data from Jean Mulcahy-Levy’s laboratory (Children’s Hospital Colorado, a participating PBTC site). It aims to overcome resistance by the administration of the autophagy inhibitor hydroxychloroquine in conjunction with dabrafenib and trametinib (for BRAFV600E mutant tumors) or trametinib alone (for BRAF fusion or NF1-driven tumors) to patients who have previously received a RAF and/or MEK inhibitor. Medulloblastoma: PBTC-053 is a phase I/II and surgical study of CX-4945, a CK2 inhibitor, for children and young adults with recurrent SHH MB (determined via methylation). Others: Several ongoing PBTC clinical trials are enrolling patients based upon IHC assessment of target expression on their tumors. PBTC-058 includes patients with recurrent ependymoma that express B7H3; PBTC-059 includes patients with recurrent ependymoma that express HER2; and PBTC-060 includes patients with high-grade glioma, medulloblastoma, or ependymoma that express survivin via immunohistochemistry. 2019 RFA Goal 5 Explore scientific opportunities in immunotherapy interventions (e.g., tumor vaccines, checkpoint inhibitors, & oncolytic viruses). Vaccines: PBTC-060 is a first-in-child study of SurVaxM, a survivin vaccine for patients with recurrent high-grade glioma, ependymoma, medulloblastoma, or newly diagnosed DIPG (post- RT and pre-progression). It is currently open to accrual in all three proposed strata: patients with recurrent embryonal tumors 10-21 years of age (Stratum 1), patients with recurrent embryonal tumors <10 years of age (Stratum 2), and patients with non-recurrent DIPG post-RT. Checkpoint inhibitors: PBTC-045 is a safety and efficacy trial of pembrolizumab for patients with recurrent DIPG, recurrent high-grade glioma, newly diagnosed or recurrent hypermutant brain tumors, recurrent medulloblastoma or recurrent ependymoma. The DIPG, medulloblastoma, and ependymoma strata are now complete. The high-grade glioma stratum met the first stage efficacy criteria and has expanded to the second stage but was closed to accrual due to slow enrollment. Similarly, the hypermutant tumor stratum closed to accrual in Nov 2024 for slow enrollment. PBTC-051 is a phase I study of the CD40 agonist antibody APX-005M. It has completed accrual. We determined the RP2Ds for patients with recurrent malignant brain tumors and for those with newly diagnosed DIPG post-RT, pre-progression. The biological correlative analyses are underway and a manuscript is expected within the next year. Oncolytic viruses: PBTC-061 is a phase II study of the oncolytic virus G207 in conjunction with a single fraction of RT. This is based upon promising safety, survival, and correlative biological outcomes seen in an institutional phase I study performed at UAB (Friedman 2021). It was activated in December 2023. CAR-T cells: PBTC-059 is a multicenter phase I and surgical study of HER2 directed CAR-T cells for patients with recurrent ependymoma. Central tumor tissue screening for HER2 expression and generation of CAR-T cells is being performed at Texas Children’s, with the remainder of the care, including CAR-T infusion, delivered at the local PBTC site. 2019 RFA Goal 6 Evaluate approaches to the local therapy of brain tumors (e.g., convection-enhanced delivery, intrathecally administered therapy, tumor-treating fields, and MRI-guided focused ultrasound). Intrathecal therapy: PBTC-058 is a trial of intrathecal radioimmunotherapy with 131-I- omburtamab (anti-B7H3). The main stratum is a phase II study for patients with recurrent medulloblastoma, with the goal of determining whether the addition of intrathecal radioimmunotherapy to temozolomide, irinotecan and bevacizumab is associated with improved EFS versus the COG ACNS0821 historical control. There is also a feasibility stratum for patients with recurrent ependymoma. Accrual was suspended in January 2023 due to the sponsor’s inability to continue to provide 131-I-omburtamab. The study closed permanently after enrolling 11 subjects. Tumor-treating fields: PBTC-048 is a feasibility trial of Optune. The original stratum was for patients with recurrent supratentorial high-grade glioma or ependymoma, and while 2 subjects need to be replaced in that stratum, we have already met the feasibility criterion for success. Additionally, as discussed in the RFA goal 7 section, we have amended the study to add a new stratum to treat patients with newly diagnosed DIPG with concurrent RT and Optune, followed by post-RT Optune in order to assess the efficacy of this approach in a phase II single-arm setting. CED: We have not proposed a study of CED during this grant cycle. In the prior grant cycle, the PBTC Scientific Committee approved a study proposal and was in the process of developing the PBTC-052 phase II study of 131-I-omburtamab for patients with newly diagnosed DIPG post-RT and pre-progression. However, development ceased due to sponsor’s withdrawal of support. This remains an area of interest for the consortium. Focused Ultrasound: A study using focused ultrasound has not yet been proposed by the PBTC. Laser Interstitial Thermal Therapy (LITT): The PBTC scientific committee approved PBTC C176, a prospective trial of LITT for pediatric patients with low-grade gliomas. The LOI has been approved by CTEP and PBTC-062 is now in development. 2019 RFA Goal 7 Evaluate novel treatment options for children with DIPG. During the current grant cycle, we have completed accrual to 3 studies that had a significant focus on DIPG and have activated an amendment to PBTC-048 to add a DIPG stratum. PBTC-047 (Panobinostat): Based upon promising pre-clinical data generated by the Monje lab (Stanford, a PBTC site), a phase I trial was performed in patients with recurrent DIPG using a 3 week on/1 week off schedule. The MTD was lower than desired due to hematological toxicity, so a second phase I stratum was opened in patients with non-progressive disease post-RT using a 1 week on/1 week off schedule. The MTD was higher, but still lower than desired, and no significant clinical efficacy at tolerable doses was observed. The manuscript was published in Neuro-Oncology in 2023. PBTC-051 (APX-005M): A phase I study of the CD40 agonist antibody APX-005M was performed and included a separate stratum for patients with newly diagnosed DIPG post-RT and pre-progression. Accrual is complete and clinical follow-up is ongoing. Biological correlative analyses are underway and the manuscript is under development. PBTC-056 (INCB7839): Based upon promising pre-clinical data from the Monje laboratory at Stanford we conducted this phase I trial of INCB007839 (ADAM10 inhibitor) in children with recurrent or progressive DIPGs or high-grade gliomas. The study recently completed accrual and the manuscript is under development. PBTC-048 (Optune): As noted in the 2019 RFA goal section 6, we have amended this study to add a new stratum to treat patients with newly diagnosed DIPG with concurrent RT and Optune, followed by post-RT Optune. This will be the first pediatric study of Optune for DIPG. The amendment was activated in September 2023.